Prospective RCT of Water exchange (WE) vs. WE plus Cap-Assisted Colonoscopy

Sedation precludes ~10% of Veterans from colonoscopy due to no escorts. They accept scheduled
unsedated colonoscopy. The option effectively manages no shows due to no escort. Other Veterans prefer
no sedation. Insertion water exchange (WE) is significantly less painful than air insufflation. The addition of
cap-assisted colonoscopy (WECAC) further reduces pain warrants confirmation. Colonoscopists with
variable experience will assess generalizability of WECAC vs. WE. Both male and female Veterans will be
recruited. Primary Hypothesis: Real-time maximum insertion pain (RTMIP) is significantly lower in the
Veterans examined by WECAC vs. WE. Secondary Hypotheses: WECAC produces significantly higher
quality colonoscopy outcomes in both male and female Veterans. Exploratory hypotheses: Co-variables
affect Veterans' report of RTMIP. Method: Consenting Veterans will be randomized (computer generated
random numbers in permuted block design with variable block sizes of 4 and 6), with code revealed at
insertion of the endoscope. Gender will be a stratification factor. The investigators will be a blocking factor
for the randomization to obtain treatment balance across investigators, however in the analytical phase the
data from these investigators will be combined to assess the primary endpoint. Consent covers agreement
to be randomized, respond to questionnaires, and allow recording of the examination for analysis, all in a
de-identified fashion. State-of-the-art endoscopic equipment is in place. The investigators and support staff
have extensive experience in both techniques. To ensure quality performance, both study and control
groups are expected to maintain successful cecal intubation rate >95%. Applicable data management,
human subject protection, adverse event monitoring and data security measures will be used. Sample size
determination. Pilot data by 4 VA investigators in scheduled unsedated male Veterans were updated. The
real time maximum insertion pain (RTMIP) [mean (SD)] was 2.7 (2.2) with WE (n=87) and 1.5 (2.1) with
WECAC (n=38). The reduction (44%) 2.7-1.5=1.2 is 1.2/2.2=0.55 standard deviation (SD) units. The sample
size/group needed to detect a difference at a level of significance of 0.0492 (adjusted for Obrien-Fleming
interim stopping rules, one interim analysis at 50% completion) with 90% power is 72 or 144 total using a
two-sided two sample t-test. Assuming 90% of subjects will be evaluable, we plan to recruit 160 male
Veterans. For the male Veterans, over a 51 month period, 260 will be eligible and approached by research
coordinators; 160 (80/arm) will be recruited. After receipt of the critique, the PI identified 9 scheduled
unsedated female Veterans (5 WE, 4 WECAC). RTMIP were WE, 6.2 (3.5) and WECAC, 3.5 (3.7). The
reduction (44%) was 2.7/3.7 or 0.7 SD unit. The female Veterans had higher RTMIP than the male
Veterans, but the percent reduction (both 44%) of RTMIP by WECAC was equivalent. The sample
size/group needed to detect a difference at a level of significance of 0.0492 (adjusted for Obrien-Fleming
interim stopping rules, one interim analysis at 50% completion) with 90% power is 43 or 86 total using a two-
sided two sample t-test. Assuming 90% of subjects will be evaluable, we plan to recruit 96 female Veterans.
For the female Veterans, over a 51 month period, 184 to 191 will be eligible and approached by research
coordinators; 96 (48/arm) will be recruited. At each VA site, the Women's Health clinic will assist the
research coordinator to inform all female Veterans of the availability of the scheduled unsedated option.
Data analysis: Prospective data will be analyzed by Fisher exact, χ2, Student t, linear or logistic regression,
nonparametric methods and hierarchical model as indicated. Interim analysis will be performed to assess
significant efficacy. Significance: Meeting patient unmet needs and preference. Long term goal: To address
adenoma detection and interval cancer prevention in unsedated Veterans with the least painful insertion
technique.

Public health relevance
In addition to providing diagnosis, colonoscopy with polypectomy is an effective intervention to prevent colon cancer. The VHA has adopted the policy of screening colonoscopy for all eligible Veterans. Up to 10.5% of disadvantaged Veterans, however, are underserved. They are unable to participate in colonoscopy performed with sedation, because they do not have anyone who can give them a ride after the examination. Colonoscopists do turn to unsedated colonoscopy to meet the Veterans' need. Other Veterans prefer to avoid sedation altogether, due to unpleasant flashbacks potentially triggered under sedation, or for other personal reasons (e.g., follow the examination awake, no need for recovery or activity restrictions after colonoscopy to save time). They are willing to try unsedated colonoscopy. The development of the least painful insertion technique to serve Veterans undergoing unsedated colonoscopy for diagnosis, and for colorectal cancer screening and surveillance is important and relevant to Veterans health.